Task A02: Murine models of Ascending UTI Infection caused by Drug-Resistant Bacteria

This contract provides for the development and standardization of small animal models for of infectious diseases, and may include efficacy testing of candidate products, including GLP studies to support licensure.